AMPHOTERICIN B W/FLUCYTOSINE TO AMPHOTERICIN B;AND FLUCONAZOLE &ITRACONAZOLE

Multicenter, double-blind, study evaluating the safety of the combination of amphotericin B and flucytosine or placebo in four divided doses for 14 days in the treatment of AIDS patients with acute cryptococcal meningitis.